A Multi-Dimensional Signature to Predict Treatment Failure in Patients with Connective Tissue Disease-Associated Interstitial Lung Disease

PROJECT SUMMARY
Interstitial lung disease (ILD) is a frequent and often fatal complication of connective tissue disease (CTD). While
immunosuppression constitutes first-line therapy for most CTD-ILD subtypes, many patients experience
treatment failure, experiencing relentless lung function decline and early death despite therapy. Unfortunately,
the clinical trajectory of CTD-ILD patients receiving immunosuppressant therapy is incompletely understood and
there are no tools to predict treatment failure. Reliably predicting treatment failure would allow for consideration
of stronger upfront immunosuppressant therapy, early initiation of antifibrotic therapy, and timely referral for lung
transplantation. Tools to predict treatment failure are urgently needed.
Dr. Pugashetti is a Pulmonary and Critical Care physician at the University of Michigan and will be principal
investigator for this mentored K23 project. Her long-term goal is to become a leader in developing predictive
biomarkers to guide therapeutic selection, thereby improving outcomes for patients with CTD-ILD. The objective
in this application is to develop predictive biomarkers of treatment failure, defined as 12-month forced vital
capacity decline, death, or lung transplant while treated with immunosuppressant therapy. In Aim 1, FVC
trajectory and cumulative incidence of treatment failure across CTD-ILD subtypes will be determined. For Aim 2,
retrospective multi-center proteomic data were used to generate an exciting preliminary signature that effectively
discriminated treatment failure from immunosuppressant response/stability. In Aim 2, Dr. Pugashetti will optimize
and prospectively validate this proteomic signature and compare test performance to a clinical prediction model.
Lastly, in Aim 3, radiomic variables will be tested for association with treatment failure and will be added to a
clinical and proteomic model to determine whether they augment treatment prediction. Findings from all three
aims will be validated prospectively.
Dr. Pugashetti’s skills gap-informed training plan consists of formal mentorship, didactic coursework, scientific
conferences, and progressively independent research activities. She is ideally positioned to successfully
complete this work given her prior research training, career development plan, outstanding institutional support
from the University of Michigan, and highly committed mentoring team with expertise in ILD and proteomics
(Oldham), CTD-ILD (Khanna), advanced biostatistical methods (Murray), radiomics (Kazerooni) and pulmonary
patient-oriented research (Han). By the end of the award period, she will develop expertise at the intersection of
ILD, rheumatology, and biomarker investigation and develop the skills to become an independent physician-
scientist. Completion of this project will lead to an R01 to assemble a multi-center, prospective CTD-ILD cohort
and investigate longitudinal changes in biomarkers of treatment failure.

Public health relevance
PROJECT NARRATIVE Interstitial lung disease (ILD) is a frequent and often fatal complication of connective tissue disease (CTD). While immunosuppressant therapy constitutes first-line therapy for most CTD-ILD subtypes, many patients are immunosuppressant non-responsive, experiencing relentless lung function decline and early death despite immunosuppressant therapy. This research will elucidate the incidence of treatment failure and leverage novel clinical, proteomic, and radiomic data to develop tools to predict treatment, ultimately aimed at improving treatment decision-making for patients with CTD-ILD.